Longevity Consortium Administrative Core

The Administrative Core (AC) provides the administrative leadership and oversight required for achieving the
scientific and operational objectives of the Longevity Consortium (LC, U19 Cooperative Agreement). The AC
will serve as LC’s central coordination and communications hub and manage its outreach activities. The
organizational structure of the LC includes five Projects, an Integrative Analysis Core, affiliated NIA Scientific
Officers, and several committees and panels that are essential to the operation of the LC, such as the
Observational Study Monitoring Board, Steering Committee, Publication Committee, Pharmaceutical and
Translational Advisory Panel and Translational Opportunity Funds Review Group, and several working groups.
The AC oversees interactions among these groups. The AC also supports the internal and external sharing of
data and results using the Synapse Platform and NIA’s ELITE Portal. The AC will organize the annual
in-person meetings in Bethesda MD, and coordinate jointly with NIA Program Officers the biannual OSMB
meetings. Outreach to the greater scientific community will be accomplished by a public-facing LC website that
will communicate program objectives, activities and research outcomes. The website will also promote and
interface with LC’s resources that are publicly accessible on the ELITE portal. Assuring timely and high quality
work to achieve long-term goals is a high priority for the LC. To deliver, four key principles will be applied by the
AC: 1. program-wide understanding of how completion of short-term milestones will lead to achieving five year
objectives; 2. requirement of setting realistic timelines and regularly reviewing progress; 3. clear definition and
assignment of roles and responsibilities within the program; and 4. implementation of standard operating
procedures with mechanisms to assure program-wide compliance as much as possible. The AC is also
responsible for composing, coordinating and submitting the interim and annual progress reports. AC’s highest
priority will be to encourage and facilitate interactions among the scientists of the five Projects and the
Integrative Analysis Core to take advantage of synergistic and complementary activities to efficiently achieve
their 5-year Objectives. The AC members also have extensive experience with fostering collaborations that rely
on trust and respect. The AC will build on this strength to facilitate collegial and transparent interactions.